Administrative Core

ADMINISTRATIVE CORE
Project Summary
All research projects and Cores will benefit from the services provided by the Administrative
Core. The Administrative Core will be responsible for the overall operation and coordination of
the CLDRC, including both scientific and administrative activities. The Administrative Core will
be coordinate the ascertainment of all participants for the Research Projects, including the new
clinic sample of 600 families and the follow-up assessments of participants from our previous
twin studies. The Administrative Core will supervise procedures to recruit and retain mentees
from underrepresented groups, monitor and mitigate known and emergent risks to all Center
objectives, and evaluate the explicit benchmarks that will be used to measure the success of the
Center. Finally, the Administrative Core will invite and coordinate the involvement of the
External Scientific Advisory Board.